Leveraging Metalloinsertors for the PET Imaging and Endoradiotherapy of MMR-Deficient Cancers

PROJECT SUMMARY / ABSTRACT
DNA repair pathways are critical for maintaining the integrity of the genome. Yet polymerase errors and
exposure to genotoxic chemicals may lead to the dysregulation of the mismatch repair (MMR) machinery, the
family of proteins responsible for identifying and correcting mispaired bases in genomic DNA. When this
machinery malfunctions - or is absent altogether - single base mismatches can accumulate, making cells
prone to the generation of single nucleotide polymorphisms (SNPs) and, eventually, tumorigenesis. Indeed, up
to 20% of all solid tumors have been shown to be MMR-deficient. Most notably, MMR-deficiency plays a
significant role in the development of hereditary nonpolyposis colorectal cancer (HNPCC). The last twenty years
have witnessed the development of octahedral rhodium complexes that selectively and specifically bind DNA
mismatches. These compounds, known as ‘metalloinsertors’, have been shown to exhibit preferential anti-
proliferative effects in vitro in MMR-deficient vs. MMR-proficient colorectal cancer cells and to inhibit tumor
growth in vivo in a murine model of colorectal cancer.
This F31 proposal is focused on the synthesis, in vitro evaluation, and in vivo validation of a novel family of
radiopharmaceuticals based on the mismatch-targeting metalloinsertor RhPBC. We first plan to synthesize non-
radioactive natI-RhPBC to facilitate the chemical and biological characterization of the probe. Subsequently, we
will create analogues of the metalloinsertor labeled with radioisotopes of iodine - either positron-emitting iodine-
124 (124I; t1/2 ~ 4.2 d) or ß-emitting iodine-131 (131I; t1/2 ~ 8.0 d) - to create radiopharmaceuticals for PET imaging
and endoradiotherapy, respectively. Specific Aim 1 will be focused on the chemical synthesis and analysis of
all three compounds (natI-RhPBC, 124I-RhPBC, and 131I-RhPBC) as well as the biological characterization and in
vitro evaluation of the compounds in a pair of isogenic human colorectal cancer cell lines that are identical except
for their MMR-proficiency (HCT116N) or MMR-deficiency (HCT116O). In Specific Aim 2, PET imaging and
biodistribution experiments will be used to evaluate the in vivo performance of 124I-RhPBC as a diagnostic and
theranostic imaging agent in a murine model MMR-deficient colorectal cancer. And finally, Specific Aim 3 will
be centered on the in vivo evaluation of 131I-RhPBC as a radiotherapeutic using biodistribution studies, dosimetry
calculations, and longitudinal therapy studies in a murine models of MMR-deficient colorectal cancer.
We contend that this project is both highly innovative and highly impactful. To the best of our knowledge,
DNA mismatches have never before been a target for nuclear imaging and therapy, and octahedral rhodium
complexes have not been harnessed as scaffolds for radiotracers. In the short term, this work could produce an
imaging agent that could be a useful tool in the clinical management of patients with MMR-deficient tumors. In
the longer term, this investigation could also yield a first-in-class radiotherapeutic that could be used against a
variety of MMR-deficient tumors, improving prognoses and outcomes for patients with these malignancies.

Public health relevance
PROJECT NARRATIVE The mismatch repair (MMR) machinery of the cell is responsible for detecting and correcting mispaired basepairs in the genome. Cells with damaged MMR machinery are unable to repair DNA mismatches, making them prone to the accumulation of mutations and ultimately tumorigenesis; to wit, up to 20% of solid tumors - including hereditary nonpolyposis colorectal cancer - have been shown to be MMR-deficient. In the proposal at hand, we describe our plan to harness octahedral rhodium complexes that bind DNA mismatches with high specificity and affinity to create a pair of radioiodinated radiopharmaceuticals for the PET imaging and endoradiotherapy of MMR-deficient colorectal cancer.